Regulatory Dynamics of the Proteostasis Network

PROJECT SUMMARY / ABSTRACT
Cancer and neurodegeneration are often thought to be on opposing ends of the disease spectrum – the
former characterized by unchecked cell growth and the latter by premature cell death. However, they are linked
by dysregulation of a common underlying cellular state: protein homeostasis (proteostasis). Proteostasis refers
to the dynamic balance of protein synthesis, folding and degradation, the maintenance of which is required for
the vast majority of cellular processes. Defects in proteostasis lead to protein aggregation, a hallmark of
neurodegenerative diseases such as Alzheimer’s, Parkinson’s, Huntington’s and ALS. Conversely, many
cancer cells overexpress proteostasis machinery to counteract high mutational loads. The long-term goal of my
research program is to define the mechanisms that healthy cells employ to maintain proteostasis and to
establish how this regulation breaks down and is hijacked in disease.
The central regulatory axis of the proteostasis network (PN) is the heat shock response (HSR), a
universally conserved gene expression program under the control of transcription factor Hsf1 in eukaryotes.
Despite its identification 30 year ago, the mechanisms that control Hsf1 activity and thereby expression of the
HSR have remained elusive. Recent work from my laboratory using budding yeast revealed a key feedback
loop that governs Hsf1 activity. We found that the chaperone Hsp70 represses Hsf1 in unstressed cells and
that Hsf1-mediated induction of Hsp70 is requied to deactivate Hsf1. Thus, Hsf1 and Hsp70 constitute a
feedback loop that promotes homeostatic adaptation to stress
This proposal builds upon this discovery and the tools and assays we have developed to answer major
outstanding questions concerning Hsf1 regulation. In Aim 1 we will define the upstream signaling events that
activate Hsf1. We hypothesize that ribosome-nascent chain complexes with C-terminal alanine/threonine
extensions (“CAT-tails”) and newly synthesized “orphan” ribosomal proteins (oRPs) trigger the HSR by
sequestering the Hsp70 co-chaperone Sis1 away from Hsf1. In Aim 2 we will define the molecular mechanisms
by which Hsp70 represses Hsf1. We will test the hypothesis that Hsp70 represses Hsf1 both by inhibiting Hsf1
DNA binding and by blocking Hsf1-mediated transactivation. In Aim 3 we will reveal novel feedback loops that
control Hsf1. We will systematically determine the contribution of all Hsf1 targets to wild-type Hsf1 activation
dynamics. By undertaking a multi-faceted analysis of the HSR – combining cell biology, molecular genetics,
biochemistry and systems biology – we will establish the signals, regulatory mechanisms and feedback loops
that govern this central adaptive circuit that lies at the heart of human diseases as diverse as cancer and
neurodegeneration.

Public health relevance
NARRATIVE Proper folding of proteins underlies nearly every aspect of cellular function and physiology and is ensured by the protein homeostasis (proteostasis) network. Defects in proteostasis result in protein aggregation, a hallmark of neurodegenerative diseases such as Alzheimer's, Parkinson's and ALS, while an overactive proteostasis network can support cancer cell growth and tumor progression. In support of the NIH mission, the research proposed here aims to elucidate the fundamental regulatory mechanisms, feedback loops, and organizational principles that govern the proteostasis network in healthy cells to gain insight into the ways it breaks down and is hijacked in disease.